Elucidating the Role of DNA Shape in CRISPR Target Discrimination

Project Summary
This proposal centers on uncovering intrinsic physical properties of DNA duplex (i.e., DNA shape) and
elucidating their roles in CRSIPR Cas9 and Cas12a target discrimination. CRISPR (Clustered-Regularly-
Interspaced-Short-Palindromic-Repeats) systems have been adapted into versatile and programmable agents
for manipulating nucleic acid targets in a genome-wide fashion, unleashing a revolution in genome editing and
manipulation that is still rapidly advancing. CRISPR-based technology is built upon specific recognition of nucleic
acids, and a major obstacle hampering its applications in therapeutic settings is the “off-target effect”, in which
uncontrolled and undesired actions of CRISPR on aberrant gene targets result in deleterious consequences.
Significant improvement of CRISPR specificity is required, and this depends on further in-depth understanding
of mechanism of CRISPR target discrimination.
Proposed work focuses on Cas9 and Cas12a that are most widely used for engineering DNA genomes. Cas9
and Cas12a both use an effector protein-RNA complex to cleave double-stranded DNAs, and select their
cognate targets based on: (i) base-pairing between the RNA guide and a segment of the DNA target-strand
designated as protospacer and (ii) a short protospacer-adjacent-motif (PAM) within the target DNA. Ca9/Cas12a
target discrimination rely on intrinsic DNA shape, which is determined collectively by the local “core” base-pair(s)
and many other factors including (distal) peripheral sequences and topological constraints (e.g., supercoiling).
However, current studies on Cas9/Cas12a target selection focus on DNA features at the core segment spanning
the PAM and protospacer, and have not yet accounted for impacts of peripheral sequences beyond direct
RNA/DNA pairing or DNA topological constraints.
We have developed unique site-directed spin labeling methods to obtain sequence-dependent conformation
(shape) of free duplexes as well as DNAs bound by proteins including Cas9 and Cas12a. Our recent work shows
that DNA sequences not involved in RNA/DNA pairing can modulate Cas9-induced DNA unwinding and cleavage,
and the information enables gene editing in cells with short RNA guides that are known to enhance specificity.
Building on these findings, we will investigate how DNA peripheral sequences and supercoiling modulate
Cas9/Cas12a target discrimination as well as affect the shape of free DNA core segments. Information learned
will be incorporated into algorithms for enhancing CRISPR targeting specificity, as well as for predicting three-
dimensional DNA shape from the linear one-dimensional sequence in a genome-wide setting. The project will
advance understanding on DNA specific recognition that is fundamental to biology, and will contribute to
development of the next generation of scientific workforce.

Public health relevance
Project Narrative The proposed work will uncover intrinsic shape of DNA duplexes and elucidate its roles in CRSIPR Cas9 and Cas12a target discrimination. Information learned will be incorporated into algorithms for enhancing CRISPR targeting specificity, ultimately advancing CRISPR-based technologies for effective genome manipulation in both basic research and therapeutic development. 1